TRANSIENT CIRCULAR DICHROISM SPECTROSCOPY

A major goal of much biomedical research is to understand how various proteins function. One approach toward this goal is to study the structure of these proteins in the hope that understanding the structures will provide clues about the function. While this has been a valuable approach, we note that protein structures change as the proteins carry out their function so that methods which can measure the dynamics of structural changes in biologically important molecules are very important. We have developed a technique which allows us to measure circular dichroism spectra, which are sensitive to macromolecular structure, with nanosecond time resolution. In this proposal we seek to renew funding for this project in order to extend the method to provide improved time-resolution in the far ultraviolet spectral region (an important spectral region for determining structures) and to apply the method to study a variety of biomedically important problems. These include studies of the function of heme proteins such as myoglobin and hemoglobin, studies of the function of phytochrome, a plant regulatory protein, studies of electron transfer processes in proteins, studies of proteins affecting muscle contractions, and studies of protein folding processes in both model peptide systems and natural proteins.